Robust and scalable Bayesian analysis tools for single cell CRISPR screens with sequencing- and imaging-based readouts

Project Summary
Single-cell CRISPR screens enable genetic perturbation studies of the functional genome at unprecedented
scale and resolution. There are two major types of single cell CRISPR screens: sequencing-based screens and
imaging-based screens. Sequencing-based screens measure the impact of CRISPR-induced genetic
perturbations on phenotypes which can be read out via single cell sequencing, such as transcriptome-wide gene
expression or chromatin accessibility. Imaging-based screens profile a range of image-based cellular phenotypes
using fluorescence microscopy, including cell morphology and the localization of fluorescently-tagged proteins.
Together, these two types of single-cell CRISPR screens can study diverse cellular behaviors which were
previously inaccessible to pooled genetic screens. However, the datasets generated by these screens are large
and complex, requiring fast and accurate computational analysis tools to interpret the phenotypic effects of each
genetic perturbation. Yet existing methods are often not statistically robust or are otherwise prohibitively slow to
analyze current datasets of millions of cells across thousands of phenotypic dimensions. This proposal explores
the use of Bayesian hierarchical models to unlock robust and scalable analysis of single-cell CRISPR screen
data. We will design two tools based on this framework: one for single-cell CRISPR screens with gene expression
readouts (Aim 1.1) and one for optical pooled screens (Aim 2.1). Both tools will use state-of-the-art statistical
methodologies to quickly and robustly infer which perturbations affect which phenotypes. This task is a critical
step towards deepening our understanding of biological pathways and gene regulatory networks using these
large-scale perturbation datasets. We will design and benchmark our methods using public datasets from both
screen modalities to evaluate their performance and generalizability. To demonstrate our methods’ ability to
generate biological insights in clinically relevant contexts, we will apply our tools to new screens from our
collaborators to aid in nominating therapeutic targets for blood disorders (Aim 1.2) and neurological diseases
(Aim 2.2). The proposed work will be broadly useful to practitioners of single-cell CRISPR screens and will help
to democratize these complex screening approaches for widespread use.

Public health relevance
Project Narrative Single-cell CRISPR screens are a new high-throughput experimental approach which can deepen our understanding of how genes and regulatory elements interact in biological networks. We propose to develop computational tools which can analyze the large and complex datasets generated by these screens to characterize the phenotypic effects of genetic perturbations at single cell resolution. These tools will be applied to identify core biological pathways underlying blood and neurodegenerative diseases and will be broadly useful to research groups performing these powerful screens.